Exome Variants Underlying Weight Gain from Adolescence to Adulthood

PROPOSAL ABSTRACT The objective of the proposed research is to investigate how genetic variation influences weight-related traits during the transition from adolescence to adulthood - a critical risk period for weight gain. Genome wide association studies (GWAS) have identified >70 well-replicated loci influencing weight-related traits, some of which vary by race/ethnicity. Few studies have examined the genetic architecture of these traits during this critical period; the discovered loci are largely common variants that explain only a fraction of the estimated trait heritability. Fine-mapping studies suggest allelic heterogeneity; many causal variants remain to be determined. Recent attention has shifted to coding variants some of which may have larger effect sizes and potential to explain more trait heritability. We build on our successes in R01 HD057194 and capitalize on nationally representative, ethnically diverse, prospective and well-characterized data on 10,581 individuals from the National Longitudinal Study of Adolescent Health (Add Health) to assess the association between weight- related traits and coding variants across a 15-year lifecycle period of dramatic weight gain between adolescence and adulthood. In addition, to make full use of this excellent resource, we combine our data with extant exome data from the Cohorts for Heart and Aging Research in Genomic Epidemiology (CHARGE) consortium (n>91,000) to further assess associations with adiposity phenotypes, an approach that will be particularly informative and powerful for the discovery of novel coding variants. Further, to fully ensure that we capitalize on the uniqueness of our longitudinal data on adolescent to adult weight gain, we combine our data with two well-characterized, age-matched cohorts with exome data (China Health and Nutrition Survey, CHNS n=1,951; Cebu Longitudinal Health and Nutrition Survey, CLHNS, n=1,691) living under different environmental conditions but experiencing high levels of weight gain analogous to Add Health. Using all three datasets, we will determine the genetic and epidemiological architecture of causal variants; identify functional SNPs and genes; and using advanced and innovative statistical modeling, examine differential genetic effects by age, time, and under varying environmental circumstances to downstream cardiometabolic risk factors (diabetes-, blood pressure-, and inflammatory-related markers). We will test novel hypotheses on tempo and timing of risk as well as address each piece of the complex system linking genetic markers, weight-related outcomes, and cardiometabolic risk factors, in the context of a variety of environmental and behavioral confounders. In sum, these data provide outstanding resources for examining low frequency coding variants associated with weight- related and cardiometabolic traits - a rapidly emerging area of science. Our longitudinal and complex analyses in this understudied age range will provide critical information about risk in the transition from adolescence into adulthood, a period of rapid weight gain when precursors of adult disease are developing. Our work will shed light on the progression of risk to inform efforts to mitigate early development of disease risk.

Public health relevance
PROJECT NARRATIVE The objective of the proposed research is to investigate how genetic variants influence temporal changes in body mass index and downstream cardiometabolic risk factors at a vulnerable lifecycle period for weight gain, with differential risk across race/ethnic groups. The proposed research will contribute to the understanding of risk in the transition from adolescence into adulthood, a period of rapid weight gain when precursors of adult disease are developing, in order to inform efforts to mitigate early development of disease risk. __SpecificAimsTextDelimiter__ SPECIFIC AIMS. Over the last 3 decades, the prevalence of obesity has risen dramatically worldwide, increasing risk for cardio- vascular, metabolic and other chronic diseases. The transition from adolescence to adulthood is a critical yet understudied period for obesity development1-3 and future cardiometabolic disease. Over five years, our study (R01- HD057194) has been capitalizing on the largest, most comprehensive longitudinal survey of adolescents ever undertaken, the multiethnic National Longitudinal Study of Adolescent Health (Add Health), to examine weight-related phenotypes during this critical 15-year lifecycle period. We have used extant, detailed anthropometric, environmental, and behavioral data, and common genetic variants to describe the effects of genome wide association study (GWAS)-identified loci4-23 and environmental factors24-28 on weight-related traits29-31 in this critical 15-year period.. However, recent studies (including our own) have demonstrated that GWAS-identified common variants vary over the lifecourse, by race/ ethnicity,19-22 and explain only a fraction of estimated trait heritability.32 Further, fine-mapping studies33 suggest allelic heterogeneity, thus many causal variants remain to be determined. Thus, recent attention has shifted to low-frequency coding variants that are, a priori, more likely to be directly functionally relevant, have larger effect sizes and potential to explain more trait heritability. Thus, we propose to extend our work from GWAS variants to thoroughly examine coding variants to better understand how genetic variation influences weight-related traits in this lifecycle period of major weight gain when antecedents of cardiometabolic disease are developing.34-36 We will genotype low- frequency (<5% minor allele frequency [MAF]), and common (>5% MAF) coding genetic variants and assess their association with BMI, waist circumference (WC), and weight change. We will apply advanced statistical models to examine differential genetic effects by age, time, and environment and in relation to downstream cardiometabolic risk factors (hypertension, diabetes, and inflammation). We will contribute our data to the ever- growing Cohorts for Heart and Aging Research in Genomic Epidemiology (CHARGE) consortium (n>91,000 as of July 2013, anticipated to grow to >250,000)37 to allow further novel discoveries using meta-analysis, an approach with demonstrated success.4-23 We will also compare Add Health results to those from two additional longitudinal, age-matched cohorts with exome array data (China Health & Nutrition Survey, CHNS n=1,951; Cebu Longitudinal Health & Nutrition Survey, CLHNS, n=1,691)38, 39 living under different environmental conditions but experiencing very high weight gain analogous to Add Health. Our specific aims are as follows: Aim 1: Using existing and newly genotyped samples from Add Health (n=10,581) and CHARGE (n>91,000), identify single coding variants and burden of variants associated with BMI and WC during a high-risk lifecourse period for obesity development. 1a. Genotype remaining Add Health samples (n=2,671 European- [EA]; 697 African- [AA]; 1,469 Hispanic- [HA]; and 504 Asian-Americans [AsA]) using the Illumina Infinium HumanExome BeadChip. 1b. Estimate effects of the ~25-50 new CHARGE SNP/gene variants on BMI and WC in race/ethnicity- stratified and race/ethnicity-combined Add Health samples. 1c. Perform locus discovery in Add Health (n=10,581) alone and meta-analyzed with CHARGE (n>91,000), total n>100,000. We will perform race/ethnicity-stratified and race/ethnicity-combined exome-wide association analysis to identify novel variants and genes associated with BMI and WC. Aim 2: Using Aim 1 variants/genes with cross-sectional evidence for association with weight-related traits, examine genetic effects across age, time, and differential environments using innovative statistical modeling techniques in total and race/ethnicity stratified Add Health data. 2a. Use longitudinal, multilevel, and mixed models to examine differential genetic effects on BMI and WC by age and time in fully adjusted models, with extension to variable environmental and behavioral effects. 2b. Develop a full longitudinal, structural model with variants showing evidence of association from 2a, to examine joint effects and pathway-based effects on WC and BMI. 2c. Extend 2a and 2b models to examine pleiotropic effects for WC and BMI along with hypertension, diabetes, and inflammation, including distinct pathways to elevated risk in the 2b models. Aim 3: Determine cross sectional and longitudinal association of single variants and burden of variants with weight-related traits in age-matched cohorts with dramatic weight gain and comparable genomic and exposure data. 3a. Conduct targeted testing of Aims 1 and 2 genes/variants with weight-related traits in age-matched but Asian only study participants from Add Health, CHNS, and CLHNS cohorts (n = 4,146). 3b. Conduct targeted testing of Aims 1 and 2 genes/variants with weight-related traits in all age-matched and race/ethnicity groups across Add Health, CHNS, and CLHNS cohorts (n=14,223).